Free Time 4 Wellness

SUMMARY
Physical inactivity is a significant contributor to risk of chronic diseases and poor health. This relationship is
particularly salient for women of low socioeconomic position in the US, for which >60% do not reach the
recommended guidelines of at least 150 minutes of moderate physical activity each week. Prior research has
documented barriers to physical activity for this population, including individual factors (e.g., limited time,
insufficient funds for gym memberships or daycare) and community-level factors (e.g., traditional gender roles,
limited access to recreation space). Prior attempts to increase physical activity have generally targeted
individuals, with only modest results. To increase physical activity among mothers living in low-resourced
communities, innovative research to identify a multilevel intervention that is easily implemented at the community
level and appropriate for mothers with little time is urgently needed. The increasing demands on mothers' time
in a new pandemic era makes freely accessible childcare an attractive option. We successfully designed and
piloted an innovative intervention to increase physical activity among mothers by combining fitness classes with
free childcare and technology to connect and support mothers at the community level. This project will evaluate
the effectiveness of our multilevel intervention, the Free Time for Wellness (FT4W) program. The conceptual
framework for the FT4W program is based on social cognitive theory and the NIMHD Minority Health and Health
Disparities Research Framework. The intervention includes: 1) free childcare at free fitness classes, and 2) peer
support activities including group play dates and group volunteer activities. No prior health intervention has
included these components that we hypothesize, separately or in combination, will increase physical activity,
based on prior theory and pilot work. We will test the FT4W program as a mixed method, cluster randomized
controlled trial conducted in community-based health centers serving racially minoritized and socioeconomically
disadvantaged populations. Participants will be randomized to one of three arms: a control arm, a childcare only
arm, or a childcare + peer support arm. The trial will evaluate: (1) the ability of FT4W to increase physical activity
within 12 weeks as confirmed by accelerometers; (2) the potential mechanisms by which the FT4W program
facilitates physical activity (e.g., environmental resources, social cohesion); and (3) potential differences in the
magnitude of effect across intersecting social stratification parameters including race/ethnicity, socioeconomic
position, and migration status. At the completion of our study, we will make the FT4W protocol freely available
and work to scale the program in low-socioeconomic areas. The proposed project thus aims to introduce an
effective multilevel intervention that is easily implemented in communities and appropriate for mothers with little
time. This scalable intervention will help reduce the barriers that prevent mothers from participating in physical
activity, preventing future high rates of chronic diseases associated with inactivity.

Public health relevance
PROJECT NARRATIVE To increase physical activity and associated chronic diseases among mothers living in low- resourced communities, innovative research to identify a multilevel intervention that is easily implemented at the community level and appropriate for mothers with little time is urgently needed. This project will use qualitative and quantitative methods in a cluster randomized control trial to evaluate the effectiveness of the Free Time for Wellness(FT4W) program, which includes free childcare at free fitness classes and peer support activities. The trial will evaluate: (1) the ability of FT4W to increase physical activity within 12 weeks as confirmed by accelerometers; (2) the potential mechanisms by which the FT4W program facilitates physical activity (e.g., environmental resources, social cohesion); and (3) potential differences in the magnitude of effect across intersecting social stratification parameters including race/ethnicity, socioeconomic position, and migration status.